Advancing sacral neuromodulation with objective analytics and prediction

PROJECT SUMMARY
Urinary urgency is the defining symptom in Overactive Bladder (OAB) which affects nearly 25% of the US
population and proportionately more women than men. Current treatments for OAB are lacking with the majority
of patients quickly withdrawing from drug treatments due to poor efficacy or side effects. When initial treatments
fail, appropriate patients may be offered sacral neuromodulation (SNM) which involves implantation of a
neurostimulator at the S3 nerve root. The majority of these devices require reprogramming (remotely
manipulating the amplitude or lead stimulation pattern) to restore efficacy, thus preventing discontinuation or
removal of the expensive device. There are no objective tools to optimize reprogramming, individualize
treatments, or predict long-term outcomes with SNM. Currently, pelvic and perineum sensation is the only
guiding feature for reprogramming and articulating the location and sensation details to providers in this
anatomic area can be difficult. SNM is thought to work by generating signals to interrupt abnormal afferent
(toward the brain) neural signals relaying sensations of bladder urgency. Components of this abnormal
neurologic response to increases in urinary urgency can be measured in the prefrontal cortex (PFC) of the brain.
Functional near-infrared spectroscopy (fNIRS) is a non-invasive tool capable of detecting brain signal changes
during increased urgency and SNM programming in the PFC. Therefore, establishment of non-invasive methods
with fNIRS to detect real-time neural responses to acute reprogramming, which are then correlated with long-
term treatment success, have the potential to transform OAB treatment in terms of efficacy, quality-of-life, and
cost-effectiveness. Furthermore, incorporating improved tools for mapping the pelvic and perineal sensation
changes during reprogramming can better quantify these sensations and allow for prediction modeling.
The proposed research has three aims: (1) To develop novel fNIRS analytics to identify PFC patterns associated
with acute SNM adjustments and correlate these patterns with treatment responses (2) To develop an instrument
for correlating perineal and pelvic sensation to acute SNM programming and treatment response, (3) To develop
a model to predict acute SNM programming responses using clinical, fNIRS, and sensory analytic data. The
tools developed in this innovative study will have applications for optimizing treatments in other forms of urgency
and voiding dysfunction. The PI, Dr. Burkett, is an Early-Career Investigator and Urogynecologist physician. This
career development award will fill gaps in her training necessary for her transition to independence in
neuroexcitation research related to bladder and voiding dysfunction. Specifically, Dr. Burkett will seek further
structured training and mentorship in fNIRS analysis and application, instrument design and implementation,
predictive model computation, professional development, and responsible conduct of research. She will work
closely with her multidisciplinary mentorship team to complete her training goals and research aims.

Public health relevance
PROJECT NARRATIVE Overactive bladder is a condition defined by urinary urgency, frequency, and urinary leakage that affects nearly 25% of the US population, leading to decreased quality-of-life and other morbidity. Patients who do not respond to typical medication treatments are offered surgically placed sacral neuromodulation, which often requires device adjustments after implantation. There are currently no objective tools to optimize this required programming, thus the goal of this proposal is to improve long-term outcomes in sacral neuromodulation through the development of objective tools to individualize programming.